Advanced optics to unlock large field-of-view multiphoton imaging for neuroscience and beyond

Project summary
Currently available optical components limit biomedical imaging. In particular, in neurobiology, standard microscope
components limit the field-of-view and speed of imaging of neuronal activity. Through prior work on BRAIN
Initiative project, we have developed approaches for new optical components that expand the field-of-view 5 to 50
times over standard microscopes, with no loss in resolution, while retaining high imaging speed. In this project,
we will develop three new products to further impact this field, enabling better imaging systems, higher quality
data, and new experiments. The three products are: (Aim 1) a new long working distance air objective with high
resolution, (Aim 2) a high performance scan lens for large field-of-view imaging, and (Aim 3) an angle-doubling
module for large field-of-view imaging with no loss in scan speed. The company will perform the design studies
and development. The company will partner with the university lab to validate and evaluate the products in
state-of-the-art experiments. The results from this project will result in innovative new optical components that
will expand the field-of-view and throughput of imaging systems in neurobiology labs.

Public health relevance
Project Narrative This Small Business Technology Transfer project will develop new optical components for biomedical imaging. The biomedical imaging enabled by these products can lead to improved understanding of neurobiology and other aspects of biology, ultimately leading to new strategies for enhancing health.